Metabolic and epigenetic regulation of skin Tregs

PROJECT SUMMARY
CD4+Foxp3+ regulatory T cells (Tregs) maintain immune tolerance and suppress autoimmunity. Recent studies
reveal that Tregs not only reside in secondary lymphoid organs (SLOs) but also enrich in various non-lymphoid
tissues. Our lab and others have characterized a unique population of Tregs in the skin with distinctive
transcriptional and epigenetic profile that maintain tissue homeostasis and suppress local inflammation. In
response to antigen stimuli and environmental cues, T cells adapt their metabolism such as aerobic glycolysis
and mitochondrial oxidative phosphorylation (OXPHOS) to facilitate their activation and differentiation. While
studies on SLO Tregs and in vitro- induced Tregs revealed a strong dependency on OXPHOS and fatty acid
oxidation, the metabolic profiles of Tregs residing in non-lymphoid tissues like the skin are still poorly
understood. This knowledge gap is partly due to limited numbers of Tregs from non-lymphoid tissues for
traditional metabolic assays and the lack of robust genetic tools for tissue-Treg specific targeting of key
metabolic enzymes and transporters. To address this issue, we utilize single-cell energetic metabolism by
profiling translation inhibition (SCENITH), a robust assay to assess metabolic dependencies and capacities of
freshly isolated cells at single-cell resolution, alongside CRISPR/Cas9-based in vivo screening/validation and
skin-Treg specific genetic knockout mouse models. Our preliminary results indicate that skin Tregs experience
hypoxia and dramatically upregulate the aerobic glycolysis pathway to support their homeostasis, metabolic
fitness, and transcriptional reprogramming in the skin microenvironment. Ablation of key transporters and
enzymes in this pathway reduces the skin-Treg compartment, decreases their Foxp3 levels and expression of
skin-Treg gene signatures, and exacerbates skin inflammation in a mouse model of contact hypersensitivity
(CHS). Recent studies have revealed an intricate link between metabolism and epigenetic remodeling as many
metabolites act as substrates for epigenetic modifications. The overall goal of this project is to dissect the
specific metabolic program governing the homeostasis of skin Tregs in their microenvironment and to elucidate
how this metabolic adaptation impacts their transcriptional and epigenetic reprogramming. First, we will use
various tissue and cell type specific genetic targeting approaches to dissect how glycolysis promotes skin-Treg
homeostasis within and outside of their tissue microenvironment and delineate hypoxia as a key environmental
signal driving the glycolytic program in skin Tregs. Next, we will use CUT&Tag and ATAC-seq to define the
molecular mechanisms by which glycolysis modulates the transcriptional and epigenetic reprogramming of skin
Tregs. Lastly, we will investigate how Treg glycolysis impacts the severity of various inflammatory skin
diseases. This work will transform our understanding of how Tregs adapt to tissue-specific cues, especially
metabolites, to support their homeostasis and function.

Public health relevance
PROJECT NARRATIVE Inflammatory skin diseases, including contact hypersensitivity, psoriasis, and atopic dermatitis, affect millions of people in the United States. We are interested in uncovering the metabolic and epigenetic mechanisms that govern the homeostasis and function of a unique anti-inflammatory regulatory T cell population residing in the skin that are critical for suppressing inflammatory skin diseases. Our long-term goal is to harness knowledge learned from these studies to devise novel tissue-Treg-targeting strategies to restore immune homeostasis in the skin and alleviate inflammatory skin conditions.